Regulation of RIG-I signaling and viral immune evasion by ufmylation

ABSTRACT
Type I and III interferons (IFN) restrict RNA virus infection. Infected cells produce IFN through signaling activated
by pattern recognition receptors such as RIG-I. Both RIG-I and downstream signaling must be highly coordinated
for efficient antiviral responses. As such, these processes are regulated by several post-translational
modifications (PTMs). These PTMs are essential for both the activation and eventual termination of RIG-I-
signaling. While RIG-I-signaling is coordinated by ubiquitination and phosphorylation, the mechanisms by which
other PTMs, such as ubiquitin-like modifiers, may regulate RIG-I-signaling are largely unknown. Our preliminary
data reveal that the ubiquitin-like modifier called ufmylation regulates multiple proteins involved in RIG-I signaling
for optimal IFN induction in response to viral infection. Further, our data suggest that ufmylation is utilized by
viruses to evade the host intracellular innate immune response. Therefore, the goal of this proposal is to
determine how ufmylation regulates the intracellular innate immune response to virus infection and viral evasion.
Based on our preliminary data, the central hypothesis is that ufmylation modulates the function of host and viral
proteins to regulate antiviral innate immunity and viral evasion. Guided by our preliminary data, this hypothesis
will be tested by pursuing the following three specific aims: 1) Define how UFL1, the ufmylation E3 ligase,
promotes the activation of RIG-I; 2) Understand the molecular mechanism by which ufmylation of a key protein
in the RIG-I signaling pathway downregulates its function and signaling; 3) Determine how dengue virus co-opts
the ufmylation conjugation system for immune evasion. In Aim 1, the molecular mechanisms by which UFL1
induces the activation of RIG-I in response to RNA virus sensing will be defined. In Aim 2, the mechanism and
dynamics of how ufmylation regulates the function of a signaling protein in RIG-I pathway will be determined. In
Aim 3, the function by which ufmylation of a DENV protein promotes DENV immune evasion, both in human cell
lines and in primary cells, will be determined. Taken together, the work proposed in this application will be
significant and innovative because it will attribute a novel immune regulatory function to ufmylation, contribute to
our understanding of its basic functions, and uncover a novel control (ufmylation) of antiviral innate immunity.
Additionally, this work will provide understanding of a host-directed process that is utilized by viruses for immune
evasion to facilitate viral replication. Overall, this work will define a new PTM that coordinates the RIG-I signaling
pathway, which will improve our knowledge of both antiviral immunity and regulation of innate immune pathways
that will lead to increased understanding of the mechanistic causes of dysregulated IFN that can ultimately result
in autoimmune disease. It will also define a new mechanism of immune evasion by flaviviruses that will have
implications for therapeutic and vaccine strategies to limit their infection.

Public health relevance
PROJECT NARRATIVE RNA viruses encompass both established and emerging pathogens, many of which cause significant morbidity and mortality worldwide and remain a constant threat to global public health, with antiviral therapies lacking for many of these viruses. The proposed study will define a new regulator of how the host senses RNA virus infection and activates the antiviral defense program, as well as defining how viruses use this new regulator for immune evasion. This study will reveal new targets that may be harnessed for the development of novel antiviral and immune therapeutics designed to limit viral infection, viral-mediated disease, and autoimmune disease.